Mechanisms of platelet stimulation in hemolysis

ABSTRACT
While sickle cell disease (SCD) is instigated by a mutant hemoglobin that polymerizes in hypoxia to cause
hemolysis and vaso-occlusion, inflammation plays a fundamental role in propagating this pathogenesis. SCD
patients are at significantly higher risk of thrombosis, which contributes to severe life-threatening complications
such as pulmonary hypertension and stroke. On a cellular level, it is well established that in SCD patients, platelet
activation is elevated and correlates with hemolysis. However, the contribution of inflammatory signaling to
platelet activation and its cross-talk with hemolysis remain unknown. High-mobility group box 1 (HMGB1), an
inflammatory mediator released by cells, has been shown to be elevated in the blood of SCD patients and to
stimulate platelet activation. Notably, the ability of HMGB1 to mediate platelet activation is dependent on the
oxidation state of critical cysteine residues in the protein. Preliminary data shows that HMGB1-mediated platelet
activation is significantly enhanced in the presence of cell-free hemoglobin (Hb), a major component of
hemolysis. Further, Hb and HMGB1 each independently increase platelet mitochondrial reactive oxygen species
(mtROS) generation, a known stimulus for platelet activation. Based on these data, I hypothesize that in SCD,
Hb oxidizes HMGB1 to increase platelet mtROS production leading to platelet activation and secondary release
of additional thrombotic stimulants including HMGB1 from platelets. Aim 1 will determine whether Hb oxidizes
HMGB1 to potentiate its activation of platelets using human healthy and sickle Hb and platelets in ex vivo
experimental models. Aim 2 will determine the mechanism by which HMGB1-induced mtROS stimulates platelet
activation. Aim 3 will utilize murine models of hemolysis to determine whether neutralizing HMGB1 attenuates
platelet activation and thrombus formation. Successful completion of these aims will elucidate a novel
mechanism of synergy between hemolysis and inflammatory signaling in potentiating thrombosis. This work will
reveal novel therapeutic targets and potential therapeutics for the treatment of thrombosis in SCD. In addition,
this project, along with the guidance of my multi-disciplinary mentorship team, career development plan, and
cutting-edge research environment at the Vascular Medicine Institute at the University of Pittsburgh, will serve
as a strong training vehicle to facilitate my independence as a researcher focused on mechanisms of thrombosis
in hemolytic disease.

Public health relevance
NARRATIVE High-mobility group box 1 (HMGB1) has a recognized role in platelet activation and thrombosis formation, but its mechanism of platelet activation in sickle cell disease remains unclear. I propose that circulating hemoglobin oxidizes HMGB1 to trigger an intracellular platelet signaling cascade that potentiates platelet mitochondrial reactive oxygen species (mtROS) and platelet activation. Investigating this novel mechanism of platelet activation will improve our understanding of the mechanisms linking hemolysis and inflammation to platelet activation and thrombosis, and establish a foundation for developing and applying HMGB1-inhibitors to prevent thrombotic complications in sickle cell disease.